EXPLORING IMPLICATIONS OF EMERGING INSIGHTS FROM PSYCHOLOGY FOR SELF-SUFFICIENCY PROGRAMS

The purpose of this project is to explore how emerging insights from psychology can strengthen programs aimed at helping families achieve self-sufficiency. In particular, the project will review the implications of existing research on psychological processes associated with goal-directed behaviors, including socio-emotional and cognitive development, executive functioning, soft skills and related areas. The project will then synthesize current research on these topics, addressing how insights gained from research can be used to promote economic advancement among low-income populations; identify promising strategies for strengthening underlying skills in these areas; and enhance measurement of changes and developments in skill acquisition. As a secondary purpose, the project will examine the extent to which insights in these areas may improve programs aimed at supporting positive parenting. The project will also develop logic models mapping how programs could incorporate psychology informed frameworks into interventions to support family self-sufficiency, employment training, career and technical education and positive parenting practices for low-income adults, and how evaluators may measure outcomes of interest. This project will conduct fieldwork to learn about existing programs that are currently integrating these frameworks into employment and training and parenting programs. The results of this project will inform future programmatic and evaluation efforts in the areas of strengthening and supporting goal-directed behavior for families. The research design includes a literature review, surveys and site visits. Mathematica Policy Research is conducting the study.